Calcium Channels, CaMKII and Mechanisms of Excitation-Transcription Coupling

ABSTRACT
In neuronal excitation-transcription (E-T) coupling, electrical signals at somatodendritic membranes drive
transcriptional activation in the nucleus, tens or hundreds of micrometers away. E-T coupling is critical for long-
term adaptation, synaptic plasticity, development and memory; it can go awry in brain disorders. Voltage-gated
L-type Ca2+ channels (LTCCs) play a dominant role in E-T coupling. Switching on these Ca2+ channels initiates
a cascade that causes activation of a nuclear transcription factor CREB (Ca2+- and cAMP- response element
binding protein), heavily studied because of its importance for learning and memory. This proposal concerns
signaling mechanisms that connect activation of LTCCs to CREB phosphorylation and other nuclear events.
We recently found that excitatory neurons use two distinct signals to mediate E-T coupling: a local rise in Ca2+
and a voltage-dependent conformational change (VΔC) of the LTCC, akin to the VΔC that triggers contraction
of skeletal muscle. Even with LTCC Ca2+ influx blocked, VΔC synergistically augmented CaMKII mobilization to
dendritic spines initiated by NMDA receptor stimulation and greatly enhanced the phospho-CREB response.
Such cooperation between glutamatergic input (NMDAR) and electrical signaling (VΔC) operates like a
temporal proximity detector, of likely significance for synaptic plasticity. We will address new questions about
mechanistic components, impact on synaptic and molecular dynamics, and signaling from neuronal
subregions. First, we will make designer L-type channels to determine how Ca2+ channelCaMKII
communication comes about. Second, we will test a mechanstic model for the multiple steps between CaMKII
liberation and mobilization to synaptic sites, its dwell at NMDARs and its eventual conformation-sensitive LTCC
trapping. Third, we will delineate the potency of local subregions to control nuclear transcription and gauge the
impact of synaptic L-type channelCaMKII signaling on immediate and 24 h changes in synaptic strength, of
relevance to multiple brain disorders, including neuropsychiatric diseases and Alzheimer’s disease.

Public health relevance
PROJECT NARRATIVE Activity-dependent gene expression links neuronal activity to decoding genomic information and thus provides a powerful support for plasticity of neurons and synapses. L-type voltage-gated calcium channels sense variations in membrane potential and use signaling known as voltage-dependent conformational coupling to pass this information on to an enzyme, CaMKII. This project studies how L-type conformational coupling joins forces with glutamate-gated calcium influx through NMDA receptors to promote local accumulation of CaMKII in dendritic spines, thus driving nuclear transcription and synaptic plasticity.